Lipidomics Shared Resource Core

ABSTRACT
Dysfunctional metabolism of bioactive lipids, including sphingolipids (SLs), contributes to the pathobiology of
cancer development and progression, the study of which is the main goal for the three experimental projects in
this PPG. The appreciation for the depth of complexity involved in SL metabolism and signaling has recently
expanded into new technical challenges since: (i) the same species of SLs could act differently depending on
the subcellular compartment, (ii) previously unappreciated structural variations in the SL molecule lead to
specific biological responses, (iii) the measurement of SL network flux revealed key nodes in the regulation of
different biological functions; and (iv) SL heterogeneity in tumor tissue is associated with specific pathological
patterns. The Lipidomics Shared Resource Core (LSR Core) was created based on the unique expertise of the
key personnel in lipid chemistry, analysis, and metabolism to support the study of SLs, with the flexibility to create
new methods and protocols required to adapt to the new questions. The Core services include: 1) qualitative
and quantitative analysis of more than 600 targeted lipid components from different biological materials (cells,
tissue, and biological fluids), primarily employing high-performance liquid chromatography-tandem mass
spectrometry (HPLC-MS/MS) technology; 2) Targeted and untargeted Imaging of lipids on tissue sections,
spheroids and cultured cells using cutting-edge MALDI technology; 3) development of biochemical tools to study
lipid metabolism (e.g. plasma membrane ceramide detection method, SL Flux Analysis utilizing a Pulse-Chase
of non-natural C17-SLs, functionalized and fluorescent ceramides); and 4) assisting PPG investigators in
experimental design, method development, data analysis, and support in data sharing. The LSR Core has been
instrumental to the success of the PPG investigators over the past 19 years by providing them with unique
capabilities and critical results that will continue to ensure the successful progress of this PPG.

Public health relevance
PROJECT NARRATIVE This Core serves as an analytical platform for the study of a large family of lipids (sphingolipids) and their metabolizing enzymes. Using targeted mass spectrometry, the Core provides unique, well-established, and consolidated methods to measure the more than 300 individual different species of sphingolipids, home- developed methods to monitor the in vitro and in situ enzymatic activities of the enzymes involved in the metabolism of these lipids and MALDI imaging on tissue samples.